The Role of Dopamine in Cognitive Resilience to Alzheimer's Disease Pathology in Healthy Older Adults

PROJECT SUMMARY
Alzheimer’s disease (AD) is characterized by β-amyloid and tau neuropathology, which are linked to disruptions
in memory performance. Advances in human neuroimaging approaches that quantify pathology in vivo have
revealed a promising target for AD therapeutics known as cognitive reserve, which is the capacity for some
individuals to have better-than-expected cognition given their level of pathology. Our proposed research
examines the role of brain dopamine in maintaining optimal cognitive function and youth-like patterns of brain
activity despite pathology. Successful maintenance of dopamine function in aging may protect against pathology-
related alterations in cognition as dopamine inputs directly into the hippocampus and supports optimal memory
performance. The functional impact of hippocampal AD-related pathology can be assessed in humans using
emerging fMRI analysis methods that measure local functional connectivity (i.e. regional homogeneity). This is
a sensitive predictor of memory performance and pathology burden in rodent models and humans and is gaining
traction as a functional neuroimaging biomarker. Local functional connectivity is also affected by
neuromodulator systems like dopamine, which may support compensatory changes in aging and could have
applications for AD. The extent to which AD-related pathology accumulation in aging interacts with dopamine
neuromodulator functions to affect local functional connectivity and memory is not known. The proposed
research will fill this gap by assessing, within an older adult sample, relationships among memory, positron
emission tomography (PET) measured AD-related pathology (tau) and dopamine synthesis capacity, and local
functional connectivity in AD-vulnerable regions. Connectivity will be measured with resting-state fMRI, and
memory will be measured with standard neuropsychological assessment. The proposed research will examine
interactions between dopamine synthesis capacity and tau pathology to test the hypothesis that elevated
dopamine synthesis capacity counteracts effects of pathology on memory and local functional connectivity, thus
representing a cognitive reserve mechanism. Aim 1 will establish age and tau pathology effects on local functional
connectivity in AD-vulnerable regions. Aim 2 will investigate interactive effects of dopamine synthesis capacity
and AD pathology on local functional connectivity and memory in older adults. This proposal uniquely integrates
AD-relevant research and dopamine mechanisms in human subjects and may support AD treatment efforts.
Completion of this research will achieve the applicant’s training goals including training in (1) multi-modal
neuroimaging, (2) memory systems in aging, (3) statistics (4) scientific communication, and (5) mentorship.
Brandeis University, Boston College, and Massachusetts General Hospital provide exceptional faculty and
neuroimaging facilities. Dr. Anne Berry (sponsor) and Dr. Elizabeth Kensinger (co-sponsor) are experienced
mentors and specialize in cognitive aging, fMRI, PET, and memory systems. The proposed project and training
will successfully advance the applicant’s qualifications for successful pursuit of a career in aging and AD,
dopamine, and memory systems.

Public health relevance
PROJECT NARRATIVE A substantial proportion of the population maintains stable cognitive function despite the development of Alzheimer’s disease (AD)-related pathology. The neural mechanisms underlying this cognitive resilience are poorly understood, though an understanding of these mechanisms has immense therapeutic potential. The proposed research will investigate the independent and interactive effects of one candidate mechanism – compensatory elevation of dopamine synthesis – and AD-related pathology on memory performance and local functional connectivity using a multi-modal neuroimaging approach in aging.